Core D: Drug Development

ABSTRACT
Core D (Myrdal) Drug Development
The Drug Development Core will serve the individual Projects and the Program Project as a whole by providing
necessary services and a unique combination of expertise in pharmacology/toxicology, pharmaceutics,
manufacturing and regulatory affairs that enable the clinical translation of topical agents. This objective will be
accomplished by the following Specific Aims: 1) To prepare stable formulations of promising new agents that
can be safely and effectively delivered to the epidermis following topical application through a) preformulation
activities, b) formulation development and c) determination of percutaneous absorption and dermal toxicity; and
2) Facilitate the translation of agents into the clinic by a) performing preclinical toxicology studies consistent with
GLP practices and monitoring the stability of the formulation lots used in these studies, and b) coordinating and
preparing New Drug (IND) applications for FDA approval and supervising production and distribution of clinical
grade supply for human trials in Project 3. Implementation of these aims will allow Project Leaders the ability to
circumvent problems with epidermal delivery which may hinder development of otherwise promising topical
agents, and optimize the crucial selection criteria for advancement of new agents to clinical testing. This will
greatly enhance the ability to translate basic science discoveries into new skin cancer chemopreventive drugs.

Public health relevance
PROJECT NARRATIVE Core D (Myrdal) Drug Development The Drug Development Core is an essential component of the Program Project in coordinating the expertise in pharmacology/toxicology, pharmaceutics, manufacturing and regulatory affairs that enable decision making to circumvent problems with epidermal delivery that normally hinder development of otherwise promising topical agents and to optimize the crucial selection criteria for advancement of new agents to clinical testing. The Core will additionally provide drug formulation support for all three projects and provide the manufacturing, toxicology and regulatory support necessary to move agents into Project 3 clinical trials.